MARC at the University of Texas at San Antonio

Summary/Abstract
The United States needs a strong, diverse workforce of Ph.D.-level scientists and engineers to meet emerging
challenges to the nation’s health and to cultivate faculty and leaders who represent our heterogeneous national
population. It is well known that when people from different backgrounds and experiences come together, their
combined perspectives and creativity lead to new approaches to challenging problems. The purpose of the
proposed MARC Program at the University of Texas at San Antonio is to recruit and train a diverse group of
undergraduates who are from ethnic minority groups, are financially disadvantaged, or have a disability– all
groups that currently play a minimal role in our national biomedical workforce. Our goal is that MARC training
will allow them to undertake the highest levels of research training, leading to the award of the Doctorate in
Philosophy (Ph.D.) degree. Holding this degree opens the door to positions of great impact and responsibility in
the biomedical research industry, government institutions, and our nation’s universities. The MARC trainees will
be majors in Biology, Biomedical Engineering, Chemical Engineering, Chemistry, Physics, Psychology, and
Mathematics. To prepare future trainees, MARC will develop a ‘pre-MARC” population of excellent applicants
and educate them about the Ph.D. careers in research, fundamental professional skills, help them connect with
faculty, and guide them towards research experiences and the MARC program. MARC will provide financial
support to trainees who enter as sophomores or juniors and complete the program as seniors, acquiring between
two and three years of experience. MARC will offer a wide array of training workshops and experiences for the
trainees and for additional “MARC-2” students who desire a Ph.D. but are not in one of the 24 MARC training
positions. MARC training for students and their faculty research mentors will ensure that the trainees have a safe
and welcoming laboratory experience; grow a network of peers, faculty, and former MARC trainees; develop the
many research and professional skills needed to be strong applicants for PhD programs; learn modern
computational techniques for working with data; and grow as leaders. Training workshops will guide the trainees
through important events in their development, among them writing an abstract (summary) of their research so
that they can present it at a scientific conference, making presentations in increasingly professional settings,
completing their first application to another school to obtain a summer research position, and finally, successfully
applying to, and interviewing for, Ph.D. programs. The MARC faculty, staff, mentors, and instructors have
supported hundreds of underrepresented students in programs for over 20 years; scores of these students have
been admitted to some of the most prestigious Ph.D. programs in the world. For this proposed five-year program,
our main goals are for all trainees to graduate with their bachelor’s degree, with at least 80% of trainees
continuing on the doctoral path, and 85% of these completing their programs and advancing to high-level careers
in the biomedical sciences that will benefit all Americans.

Public health relevance
Project Narrative The overall goal of the MARC program at the University of Texas at San Antonio is to provide a comprehensive evidence-based training and support infrastructure that enables underrepresented undergraduates at UTSA to develop as biomedical and behavioral scientists who transition into, and complete, doctoral level training programs (e.g. Ph.D. or M.D./Ph.D.). Our trainees will contribute to public health by enhancing the creativity and productivity of the national biomedical and behavioral workforce. Those who follow an academic path will also help to diversify the nation’s universities as faculty who are more representative of all Americans.